CHARACTERIZATION OF COGNITIVE INFERENCE IN A RODENT MODEL OF HIV-ASSOCIATED NEUROCOGNITIVE DISORDER

In the current funding period, we have begun characterizing the performance of the background rats on several cognitive tests that will be used. In initial testing on sensory preconditioning, which was completed and analyzed, we have found that the background population performed normally like Long-Evans controls that we normally used. there is no further information to summarize ...............................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................